Columbia Population Research Center - Development Core

Abstract - Development Core
The overall goals of the development core (DC) are to increase the scientific impact, innovation, and
productivity of CPRC's population dynamics researchers, increase their competiveness for peer-reviewed
external funding, and support the professional development of junior scientists. To achieve these goals, the
specific aim of the DC is to design, implement, and monitor a comprehensive set of services and activities to
advance the aims of the center, which are to: (1) nourish a vibrant cross-campus intellectual community of
population researchers at Columbia, fostering the development of junior population scientists and encouraging
collaborations among population scientists and between population scientists and scientists in other
disciplines; (2) advance population research in CPRC's four primary research areas: children, youth, and
families; reproductive health and HIV/AIDS; immigration/migration; and urbanism; (3) continue to be a
leading population center focused on research on inequalities in the health and well-being of vulnerable
populations, and on public policies relevant to those populations; and (4) take advantage of Columbia's
location in New York City by partnering with city policy makers and practitioners to address mutual research
interests. The DC, co-chaired by Neeraj Kaushal (Social Work) and Matthew Neidell (Health Policy and
Management, Mailman School of Public Health), two highly qualified researchers who have led the core since
2015, provides the following services and activities:
1) The seminar series, which represents the heart of the CPRC's intellectual community;
2) Primary research area (PRA) groups whose activities generate multiple cross-campus collaborations to
advance population science;
3) Working groups, clusters of researchers organized around a specific research topic or problem and
committed to developing either a research project or a CPRC-wide initiative;
4) Conferences and workshops that bring together researchers across CPRC, providing an opportunity for
researchers to interact and to develop plans for new collaborations or projects;
5) A seed grant program that galvanizes population research at Columbia by providing strategic support for
small scale, innovative projects that lay the groundwork for larger studies to advance population dynamics
research, with priority for junior scientists and for new collaborations across disciplines and/or across campus;
6) A junior scientist mentoring and support program that promotes the development of junior faculty and
research scientists conducting population research through a range of services including a new editing service;
7) A visiting scholars program that welcomes visitors whose work ties in closely with CPRC's PRAs; and
8) A proposed new Invited Scholar program that will allow two CPRC seminar presenters each year to stay for a
week to provide consultation and mentorship to junior scientists, and develop possible collaborations.